Proteomics Core Facility

In 2022, PCF supported over 30 investigators within and outside NINDS, worked on more than 50 projects, co-authored in at least 6 papers.
PCF is equipped with a Thermo Fisher Orbitrap Lumos mass spectrometer with an nanoflow Ultimate 3000 HPLC, and an Agilent 6230 LC-TOF system.
PCF seeks to provide high quality proteomics services on the following areas:
1. Intact Protein molecular weight measurement.
2. Protein identification from in-gel, in-solution, and on-beads samples.
3. Protein quantification from in-gel, in-solution, and on-beads samples using label-free or labeled approaches such as SILAC, iTRAQ, and TMT methods.
4. Identification of PTMs including phosphorylation, acetylation, ubiquitination, glutamination and disulfide linkage characterization.
5. Relative quantification of protein PTMs such as global phosphoproteomic analysis.
6. Develop methods for unique projects.
In addition, PCF staff also train users on instrument operation, educate users on mass spectrometry-based techniques, stay informed on new techniques and devices, and make them available to PCF users when possible.